Endothelial oxygen sensing and metabolic reprogramming in AKI to CKD transition

PROJECT SUMMARY
Ischemic acute kidney injury (AKI) often progresses to chronic kidney disease (CKD) through
maladaptive repair. Hypoxia, present in both AKI and CKD, triggers a response mediated by the
oxygen sensing prolyl-4-hydroxylase domain-containing proteins (PHD1-3), regulating Hypoxia-
Inducible-Factors (HIF). Despite the critical role of endothelial cells in responding to hypoxic injury,
the molecular mechanisms by which PHDs in these cells impact post-ischemic kidney repair
remain unclear. This knowledge gap is significant, given the pressing need for therapies
preventing AKI to CKD transition. Our recent studies on mice and humans revealed compartment-
specific differences in PHD isoform expression in the kidney vascular endothelium. Using genetic
approaches, we found that concurrent inactivation of endothelial PHD1, PHD2, and PHD3
promotes maladaptive kidney repair, leading to tissue injury, fibrosis, and inflammation. Single-
cell RNA-seq analysis showed endothelial hypoxic and glycolytic signatures, which were also
observed in severe human AKI. This metabolic program was coupled to upregulation of the
SLC16A3 gene encoding the lactate exporter monocarboxylate transporter 4 (MCT4). Strikingly,
treatment with the MCT4 inhibitor syrosingopine restored adaptive kidney repair and suppressed
EC-derived proinflammatory responses. Finally, among the three PHD isoforms, we identified
endothelial PHD3 as the critical isoform regulating post-ischemic kidney fibrosis. The goal of this
proposal is to build on these exciting discoveries and harness hypoxic signaling-dependent
mechanisms regulating endothelial cell glycolysis/MCT4 signaling to inhibit AKI to CKD transition.
Our central hypothesis is that endothelial PHD3 activity promotes adaptive kidney repair by
inhibiting endothelial pro-inflammatory responses through suppression of HIF-driven
glycolysis/MCT4 axis. We propose two Aims: (Aim 1) Inhibition of the endothelial MCT4 axis
promotes adaptive kidney repair following ischemic AKI by inducing favorable metabolic
reprogramming; (Aim 2) Endothelial PHD3 promotes adaptive kidney repair following ischemic
AKI by suppressing endothelial derived pro-inflammatory responses through HIF1. The proposed
research is innovative because it is the first to investigate the mechanistic basis and therapeutic
potential of endothelial hypoxic dependent glycolysis/MCT4 axis in post-ischemic kidney repair
using novel genetic models in conjunction with sophisticated transcriptomic and metabolic
approaches. Completion of this project will open new avenues of targeted therapeutic possibilities
to prevent AKI to CKD transition.

Public health relevance
PROJECT NARRATIVE Currently, there are no effective therapies to promote kidney repair following acute kidney injury. Consequently, many patients develop chronic kidney disease and other long-term risks including cardiovascular events and reduced quality of life. By investigating the mechanistic basis and therapeutic potential of endothelial hypoxia-induced glycolysis/MCT4 axis in post-ischemic kidney repair, our studies will stimulate new areas for experimental therapeutics in AKI.